Core C: Administrative Core

Core C Summary
The Administrative Core (Core C) will provide four major services: Professional Direction for the aggregate
PPG, Communication and Coordination of PPG-related activities, Organization of Program Project
Meetings, and Biostatistical Support for Component Project Investigators and Core Leaders. The
Administrative Core will therefore provide strong centralized scientific and administrative leadership to facilitate
synergistic interactions between the three Projects and three Cores of this Program Project.
Dr. Richard Peek, Principal Investigator, has primary responsibility for all aspects of the Program and the
Administrative Core. He will be aided by the Project Leaders, Core Directors, members of the Scientific
Advisory Boards, and administrative personnel. The administrative staff of the Core will oversee all annual
budgets, monitor expenses, provide monthly statements of financial activities, and maintain the secure,
dedicated PPG website (https://my.vanderbilt.edu/hpinflammationcancer/). Biostatistical analysis and
interpretation will be provided to all Program Project participants by Dr. Tatsuki Koyama, the Administrative
Core's Biostatistician. In addition, all Program-related meetings will be scheduled through this Core. These
include monthly meetings of Project and Core leaders to evaluate productivity, allocate core usage and
Program resources, and discuss future directions. A bi-monthly scientific meeting will also allow investigators
to present current data, identify problems, and discuss solutions. Arrangements for the Scientific Advisory
Board meetings, planned for every 1.5 years of the Project period, as well as generation of materials to be
reviewed, will be handled through the Administrative Core. Finally, this Core will prepare, generate, and
assemble materials required for the annual progress reports and will ensure that all additional NIH and
institutional reporting requirements concerning the Program Project's activities are completed in a timely
manner.
!

Public health relevance
Core C Narrative Administrative Core C will facilitate the activities required to identify bacterial, host and dietary factors that influence gastric carcinogenesis. !